IGF::OT::IGF Med-Check - Medication Adherence System; POP 8/29/13 - 2/28/2014; FY

The Contractor will design, develop, and evaluate the MedCheck prototype - a comprehensive web and mobile integrated, medication adherence system.